Impact of IL-27 on monocyte responses to Toxoplasma gondii infection

Project Summary
The cytokine IL-27 is a critical mechanism for restraining immune hyperactivity during infection. During
Toxoplasma gondii infection, the loss of IL-27 results in a lethal, CD4+ T cell mediated immune response as
well as elevated inflammatory cytokine responses and systemic thrombosis. How these mechanisms mediate
pathology, and possibly intersect with one another, is unclear. GM-CSF production by CD4+ T cells is
enhanced in IL-27 deficient mice, and we have recently observed that blockade of this cytokine leads to
survival of infected IL-27-/- mice. GM-CSF can enhance monocyte and macrophage responses as well as
contribute to immunothrombosis, suggesting that this may be a potential central mechanism by which IL-27
mediated protection is achieved. Additionally, we have observed that the loss of IL-27 results in enhanced
monopoiesis and monocyte responses to infection. Monocytes do not express the IL-27 receptor, but long-term
hematopoietic stem cells (LT-HSCs) do and can be skewed towards several differentiation pathways by IL-27.
Thus, we hypothesize that the loss of IL-27 leads to enhanced monocyte development during infection which
may in turn be impacted by GM-CSF during later stages of infection to mediate pathology. To test this, we will
analyze if HSC development and monocyte phenotypes are impacted by IL-27 during the early stages of
toxoplasmosis and if enhanced monocytes responses are pathological in this setting. This will be achieved
through a combination of cell transfers, high-dimensional flow cytometry, and scRNA-seq as well as selective
depletion experiments. We will then determine the mechanisms by which GM-CSF mediates pathology in the
absence of IL-27. This will be done by blocking GM-CSF during infection of IL-27-/- mice and analyzing the
immune parameters connected to pathology. Following this, the GM-CSF receptor will be selectively removed
from potential cell types to determine if this rescues IL-27 deficient mice during infection. Together, these
studies will enhance our understanding of cytokine driven pathologies and mechanisms of immune protection.

Public health relevance
Project Narrative In the absence of IL-27, mice infected with the parasite Toxoplasma gondii develop a lethal, T cell-mediated inflammatory response, but the basis for their sepsis-like reaction is poorly understood. Our studies indicate that this immune pathology is characterized by enhanced monocyte responses and the overproduction of GM- CSF. The aim of this proposal, then, is to understand how IL-27 regulates monocyte responses and protects from pathology, and the information gained from this work will further our understanding of cytokine regulatory circuits and how these can be targeted for human health.